THE SOLUTION OF REACTION-DIFFUSION SYSTEMS IN BIOLOGY

This project consists of the development of numerical methods and mathmatical software for the solution of ordinary and partial differential equations that describle dynamic physiological processes.